DAY TREATMENT FOR PREGNANT DRUG USING WOMEN

The purpose of this five year randomized trial of a neighborhood based comprehensive day treatment for pregnant illicit drug users is to determine whether random assignment to a comprehensive, multidimensional program is better when compared to control women who receive standard care.